Occupational Safety and Health Training Grant : MS ISE/ Safety and Ergonomics

7. Project Summary / Abstract
The long term objectives of this program are to 1) increase the number of engineers who understand that they
have a direct effect on the safety of workers who work with the equipment and work systems engineers design,
and 2) increase the number of engineers who choose to go into applied or research positions in the area of
occupational safety and health.
Traineeships in Occupational Safety and Ergonomics are available in the Department of Integrated Systems
Engineering (ISE) at The Ohio State University. These provide educational opportunities to engineering
students at the master's level who are interested in pursuing industrial, consulting, or academic careers in
occupational safety and ergonomics or related areas. Plans of study typically require 4-5 semesters to
complete. Students take courses in occupational biomechanics and ergonomics, cognitive systems
engineering, occupational health, occupational safety, human error and systems failure or resilience
engineering, and experimental design. Students are trained in responsible conduct of research practices and
have opportunities to get involved in cutting edge research that addresses a number of original NORA Priority
Research Areas, including Low Back Disorders, Musculoskeletal Disorders of the Upper Extremities, Traumatic
Injuries, Emerging Technologies, Organization of Work, Special Populations at Risk, Exposure Assessment
Methods, and/or Intervention Effectiveness Research. Research projects, seminars, internships, a safety
practicum, and other opportunities expose students to several sectors in the current NORA Sector-Based
Approach such as Healthcare, Manufacturing, Public Safety, Service workers, and Warehousing. Students
learn from OSU faculty, experienced OHS practitioners, and workers. While students learn about safety and
ergonomics fundamentals, they also learn about emerging trends and concepts, such as resilience as an
approach to safety & engineering and wellness approaches to occupational safety and health. Laboratory
facilities and equipment the students work with are state-of-the-art, including OSU's Spine Research Institute,
and the OSU Libraries system is second-to-none.
OSU's College of Engineering and the Department of Integrated Systems Engineering continue to refine and
improve strategies for recruiting and retaining top-notch graduate students from groups that are
underrepresented in engineering, and our training program has participated in these strategies when recruiting
participants for the program. Advisory Board members bring experience from labor, industry, research,
government, and education, and provide the program with important, relevant perspectives, as well as
providing direct support to students through internships, safety practicum sponsorships, guest lectures in
classes, and seminars. The training program provides Ohio, a state with more than 921,000 employers and
5.2 million workers, and the nation with engineers with training to identify and address occupational safety and
ergonomics hazards in a wide variety of work settings. Program graduates become valuable employees
because of the breadth of their training (including in research methods, occupational safety, occupational
health, and ergonomics/human factors/cognitive systems engineering), diverse sector exposure (service
sector, manufacturing, warehousing, healthcare, and others), and instructor exposure (academics and
experienced professionals), or students may opt to build upon that strong foundation of knowledge with further
education and training at the doctoral level.

Public health relevance
8. Project Narrative See Program Plan under PHS398 Research Training Program Plan